Workforce Development Core

Enhancing the size and quality of the genomics workforce is critical if the nation is to benefit from anticipated advances in genomic science and precision medicine. The Workforce Development Core will be focused on expanding the cadre of individuals with expert knowledge and skills in human genomics and on fostering genomic literacy among members of the general public. The Core will advance the career development of scientists and trainees in genomic research, helping to address the broad national need for more scientists in genomics and biomedical research. The Workforce Development Core will leverage two highly innovative research projects to provide genomics training and research experiences to students, postdocs, residents, and faculty from across the University. We will actively seek faculty trainees from outside biology and biomedical sciences by working with the College of Education and the College of Engineering and Computer Science. The Workforce Development Core will work to improve genomic literacy and enhance interest in genomics and careers in genomics through training targeted to K-12 educators and healthcare providers. Working closely with the College of Education, we propose to offer innovative short courses in genomics, genomics research experiences, and dissertation or thesis support to graduate students in education and teachers in local school districts. We will provide genomics-oriented research career enhancement opportunities through creation of a Genomic Research Success Program that will provide training in grantsmanship and dissemination of research results. Additionally, we will foster synergy with other existing institutional and national career development activities. Finally, we will establish a mentoring program to foster the growth of research in human genetics and genomics through one-on-one mentoring and guidance in genomic research. Working with local school districts, we will participate in career days and other activities to promote awareness of careers in genetics.